Scientific Information Management and Literature-Based Evaluations for the DTT - Novel Tools for Systematic Review Automation

New tool/method development is a critical component of the Division of Translational Toxicology’s scientific information management for activities related to literature-based evaluations, necessitated by the volume of literature to review, complex designs, and varying levels of reporting of research studies in the literature. In addition, the need to prepare high quality text and graphics necessitate these activities. This project focuses a robust effort on the development of automated processes that can increase efficiency in literature-based evaluations. Keywords: systematic review, publication.